Understanding the Numbers: Quantitative Literacy for Experimental Rigor

PROJECT SUMMARY
Quantitative literacy is an essential component of rigorous research. Quantitative literacy incorporates
mathematical knowledge, statistics, reasoning, and data and visual literacies to assign meaning to numerical
data. In scientific research, being quantitatively literate includes being proficient in contextualizing quantitative
datasets and reading and reporting numerical data. Being quantitatively literate is critical to identifying and
avoiding weakness in rigor. Our team will design engaging, clear content for the purposes of providing a
foundational understanding what quantitative literacy is and its role in scientific rigor, developing strategies and
practices in interpreting, analyzing and contextualizing numerical data analysis, and educating learners on best
practices in reporting numerical data to promote scientific rigor. Our educational design invites novice,
intermediate and advanced learners to review and interact with quantitative literacy concepts through five
different learning units. Users have the option to progress through the units covering foundational principles of
quantitative literacy, practices in contextualizing data, interpreting statistics, evaluating and utilizing illustrative
reports and reporting quantitative data, or can acquire knowledge through independent activities, catering to
individualize learning needs. Our expertise and practice in quantitative literacy as well as in building
educational programs will be utilized to construct educational experiences that will ultimately improve scientific
rigor.

Public health relevance
PROJECT NARRATIVE Quantitative literacy incorporates mathematical knowledge, statistics, reasoning and attitudes to assign meaning to numerical data. Being proficient in quantitative literacy is a vital skill in scientific research, contributing to a thorough understanding of one’s field of study, appropriateness in one’s experimental design, and one’s ability to report data clearly. We propose an innovative and interactive training program that will provide users at multiple experience levels with a broader knowledge base of quantitative literacy skills in order to best promote scientific rigor in their work.